Shorter and more effective oral regimens for M. abscessus pulmonary disease

ABSTRACT
Mycobacterium abscessus (Mab) accounts for most pulmonary infections caused by fast-growing non-
tuberculous mycobacteria (NTM). Incidence and prevalence rates are increasing throughout the developed
world. There is currently no reliable cure for Mab pulmonary disease (Mab-PD) despite long multidrug treatments
that include parenteral and poorly tolerated antibiotics. Among the factors driving the refractory nature of Mab-
PD is intrinsic resistance of the pathogen to many drug classes. Here we propose complementary approaches
to discover all-oral sterilizing drug regimens, either entirely made of FDA-approved agents for consideration as
salvage therapy and clinical trials or integrating novel preclinical and clinical candidates for progression through
the development pipeline. To shorten treatment duration in Mab-PD patients who often present with
compromised immune defenses, we build novel regimens around a backbone of bactericidal agents that can
rapidly reduce bacterial burden to overcome the limited contribution of the immune system. Bacteriostatic agents
with established clinical utility or promising clinical trial results will be screened and included if they preserve the
bactericidal activity of the backbone. First, we will propose optimized regimens with the greatest potential for
sterilization according to (i) their collective ability to reach and clear bacterial populations at the site of disease
and (ii) efficacy in a mouse model of Mab infection (Aim 1). To enable a more mechanistic approach to regimen
development, we will characterize the cascades of drug-induced damage and system collapses leading to Mab
cell death, using physiological readouts established in other bacterial species. Physiologic signatures of lethality
could help design drug combinations that include bacteriostatic agents yet potentiate the bactericidal activity of
partner drugs (Aim 2). To identify the determinants of intrinsic and acquired resistance to key drug classes, we
will combine conventional mutant selection with genome wide CRISPR interference screens. The two
approaches overcome each other’s limitations, as illustrated by the preliminary identification of specific D,D- and
L,D transpeptidases as targets of a carbapenem in Mab, and a putative novel β-lactamase as a determinant of
intrinsic resistance, through a CRISPRi screen. Chemical-genetic interactions will also reveal novel targets of
synergy for the discovery of optimized drug combinations. Importantly, we expect that CRISPRi screens will
uncover mechanisms of intrinsic resistance to guide future medicinal chemistry campaigns, as we have
successfully accomplished with rifamycins overcoming ADP-ribosylation in Mab. We have assembled a
multidisciplinary team of experts in microbiology and pharmacology, molecular genetics and genomics and
mouse models of Mab infection. Together, we will develop enabling tools and concepts to propose novel but
safe therapeutic countermeasures that can be readily tested in patients or form the basis for preclinical and
clinical development.

Public health relevance
NARRATIVE Current treatments of Mycobacterium abscessus lung disease are lengthy, ineffective, rely heavily on injectables and are associated with frequent side effects. Using in vitro assays and mouse models of disease we will identify shorter, more effective, oral and safe treatments that can be tested in patients. In parallel we will study the physiological mechanisms of drug-induced bacterial cell death, and the genetics of resistance and susceptibility, providing the basis to develop the next generation of drug regimens.